Training in Social Psychology

DESCRIPTION (provided by applicant): Funds are requested to support six (6) full-time predoctoral trainees per year. The program seeks to develop researchers able to contribute to analysis of social phenomena and problems and an understanding of underlying processes. A foundation of "core" courses in the major subdisciplines of our field, regular research meetings and special topic seminars, and an intensive research apprenticeship are employed to enhance trainees' skills in conceptual analysis, theory development, and research. The overlapping interests and shared commitment of our faculty naturally lead our students to emphasize work that speaks to important social problems and their amelioration. Ongoing work involves the role of basic cognitive, motivational, and affective processes in intergroup conflict in the under-mining of minority students' self-confidence and aspirations, and various social and health problems such as interpersonal violence, debilitating shyness, and depression. Three themes-the role of self and self-reflective processes, the significance of emotion and emotional regulation, and the need for a broader cultural perspective-have played a particularly important role in guiding our efforts. Approximately 85 students apply for admission to the Stanford social program each year, of whom 3 or 4 especially promising candidates enter the program and plan a course of study suited to meet the Department's formal requirements and their own interests and professional aspirations. As they progress, students take increasing responsibility for originating and pursuing their research. Students are encouraged to work with multiple advisors, and to cross traditional disciplinary borders. Numerous interdisciplinary programs at Stanford offer additional research and educational opportunities. Most of our graduates take academic positions, but significant number elect positions in applied settings concerned with health care, education, or new communication technologies.